Administrative

is needed, use Project/

Public health relevance
This Core serves a key function in leading and coordinating this highly translational Program Project Grant toward a better understanding of mechanisms and effects of photodynamic therapy and its clinical application in the treatment of malignant disease.